Leveraging biological insights to enhance immunotherapies

SUMMARY/ABSTRACT
Neuroblastoma (NB) is the only pediatric solid tumor for which immunotherapy has become part of the standard
of care, with FDA approval of two anti-GD2 antibodies. Immunotherapy with anti-GD2 is utilized both during
upfront therapy and for patients who have relapsed. Despite the availability of these important drugs,
approximately 50% of NB patients relapse and eventually die from their disease. Those patients who survive are
left with debilitating long-term effects, including growth retardation, hearing loss, infertility, and even secondary
malignancies. Many of these secondary effects derive from high dose chemotherapy, while immunotherapy
carries a much lower risk of long-term effects. Thus, enhancing the efficacy of immunotherapy for NB could
potentially cure more patients while causing fewer debilitating late effects in survivors. This proposal pairs
expertise in both antibody and chimeric antigen receptor (CAR) T cell immunotherapy with biological insights
into immunotherapy target biology and expression. Our broad hypothesis is that heterogeneous and low surface
antigen density of GD2 and other targets can limit the efficacy of immunotherapies in NB, but that this can be
overcome through therapeutic maneuvers that increase their expression and/or modulate immune cell function.
CARs are synthetic receptors that redirect the specificity of a T cell against a surface molecule expressed on
tumor cells. Our laboratories have defined the antigen density threshold for CAR T cell activity, and have
demonstrated that low level expression of target antigens can drive resistance to these immunotherapies. We
have successfully reengineered CARs to lower their activation threshold and enhance CAR T cell activity at low
antigen density. We have also focused on enhancing antibody based immunotherapies in NB focusing on
clinically validated anti-GD2 antibodies. We recently discovered that NB cells can lower the density of GD2 on
their surface, avoiding immune cell killing. We uncovered the mechanism of GD2 regulation in NB, linked GD2
expression epigenetic cell state, and reversed GD2 downregulation with FDA approved drugs. The work
proposed in this renewal application will address the challenges of low target antigen expression to enhance the
efficacy of immunotherapies in NB. We will test our central hypothesis in three Specific Aims: 1) Define and
modulate the GD2 antigen density threshold necessary for therapeutic success of anti-GD2 based
immunotherapies; 2) Optimize approaches to deliver CAR T cells in combination with EZH2 inhibitors to
overcome antigen negative/low resistance; 3) Engineer GD2 and B7-H3 CAR T cells to overcome low target
antigen density in NB by utilizing two novel platforms alone or in combination. This project is significant because
it will result in new immunotherapeutic approaches for the treatment of children with NB, while also uncovering
fundamental mechanisms driving successful immunotherapies that can be broadly applied across many types
of cancer. This Project will address a major unmet need for new and effective therapies for children with NB that
can cure more patients and reduce the burden of debilitating late effects.

Public health relevance
PROJECT NARRATIVE Project 4 is relevant to public health because it seeks to discover the fundamental reasons why cancer becomes resistant to immunotherapies such as antibodies and chimeric antigen receptor (CAR) T cells within a Program focused on the childhood malignancy neuroblastoma. The research is highly relevant to the NIH mission and the urgent unmet need of developing rational, evidence-based effective therapeutic strategies to reduce the health burden of high-risk neuroblastoma and other human cancers.